Bispecific antibody to target FVIII-specific B cells

Abstract:
The antibody response to factor VIII (FVIII) in hemophilia A patients is a critical
problem since these antibodies (called inhibitors) block the therapeutic activity of
FVIII. The current treatment for inhibitor patients, called immune tolerance induction
(ITI) is expensive and fails in many cases. Thus, improved methods to eliminate
inhibitors is an unmet need. We propose to achieve this by direct targeting and
deletion of FVIII-specific B cells.
Our lab has developed several cellular approaches to prevent and reverse inhibitor
formation, including the creation of novel engineered FVIII-specific regulatory or
cytotoxic T cells. These human and mouse T cells were engineered to express FVIII-
specific chimeric receptors or FVIII antigen domains, the latter which can interact with
naïve or memory B-cell precursors of FVIII-specific plasma cells to block or reverse
inhibitor formation. We named these latter cells “BAR” for B-cell-targeting Antibody
Receptor cells. These personalized cellular therapies are effective at suppressing
FVIII-specific B-cell responses.
Our overall goal herein is to build on our successful cellular approaches by creating
protein therapeutics that would target and eliminate FVIII-specific B cells, using new
B-cell receptor transgenics specific to a FVIII domain. Thus, we have designed
chimeric immune conjugates that link cytotoxic CD8 T cells with FVIII-specific B cells
via expression of FVIII domains, as in the “BAR” approach above. We propose to
evaluate them for cytotoxicity against FVIII-specific B cells, and to provide proof of
principle to modulate anti-FVIII responses in vitro and in vivo in a mouse model of
hemophilia A. These immunoconjugates have the potential to eliminate anti-FVIII
inhibitors in patients.
1

Public health relevance
Narrative Our lab has focused on developing approaches to prevent or even reverse adverse immune responses, such as inhibitor formation to therapeutic factor VIII, a major clinical problem in hemophilia a. We have previously engineered human and mouse T lymphocytes with antigen-specificity to modulate these adverse immune responses. In this proposal, we will develop an alternative strategy to use bi-specific protein conjugates to target the specific B lymphocytes that produces these inhibitory antibodies, as a step for future clinical translation.